MEDICATION SUPERVISION AMONG HIV-INFECTED WITH COGNITIVE DEFICIT

To improve medication supervision and adherence among ambulatory HIV+ outpatients whose cognitive deficits prevent them from effectively taking medications (protease inhibitors and anit-retrovirals).